Biological effects, hormone levels and mechanisms relevant to HIV-1 infection for women randomized to the injectable contraceptives depo-medroxyprogesterone acetate or norethisterone enanthate.

The proposed research seeks to understand plausible biological mechanisms whereby different injectable
contraceptives may or may not affect susceptibility to infections such as HIV-1. High usage of injectable
contraceptives correlates with high prevalence of HIV-1 infection in sub-Saharan Africa and South Africa. A
strong gender bias for HIV-1 infection occurs towards young women in sub-Saharan Africa. Depo-
medroxyprogesterone acetate (DMPA-IM), a three-monthly, intramuscular (IM) injection of 150 mg MPA is the
most commonly used, while Norethisterone enanthate (NET-EN), a two-monthly, IM injection of 200 mg NET-
EN is widely used in South Africa, especially among young women. Higher quality observational clinical data
show a significant 40-50% increased risk of HIV-1 acquisition compared to no hormonal contraception for
DMPA-IM. Limited observational studies found no significant increased risk for HIV-1 acquisition compared to
no hormonal contraception for NET-EN, while two head-to-head comparisons found a potential 32-40%
increase in HIV-1 risk for DMPA-IM versus NET-EN users. Recent results from the randomized ECHO trial do
not inform on the risk of HIV-1 infection of DMPA-IM compared to NET-EN, or for DMPA-IM compared to no
hormonal contraception. However, they do suggest progestin-specific effects with a best estimate of 23-29%
increased risk for DMPA-IM compared to a levonorgestrel-containing implant over only 18 months. It is
possible that a 32-40% difference in HIV-1 risk between DMPA-IM and NET-EN, taking into account both
vertical and horizontal transmission, may have an important impact on the epidemic over a longer time period
in high risk populations and may be highly relevant for individual women who desire informed choice. Given the
potential for confounding factors in observational studies, a definitive answer as to the relative HIV-1 risks of
DMPA-IM and NET-EN remains elusive. Another approach to gaining insights into the relative risks of DMPA-
IM versus NET-EN is to obtain and evaluate high quality clinical biological data on responses strongly
implicated in HIV-1 acquisition from women randomized to DMPA-IM and NET-EN. We will obtain archived
samples from such a randomized trial (The WHICH (part 1) trial), and measure biomarkers of immune function
and other potential markers of HIV-1 susceptibility. We will also perform a series of in vivo and ex vivo
mechanistic studies to investigate plausible biological mechanisms for MPA and NET for HIV-1 acquisition and
determine how those results correlate with the clinical data. The results will provide insight into whether and
how DMPA-IM and NET-EN exert different biological effects, with implications for HIV-1 acquisition in women.
The results will contribute significantly to scientific knowledge in the contraception and HIV-1 fields. They are
likely to impact on clinical practice, health policy and international guidelines, to either reassure the
interchangeable use or suggest preferential use of one of these injectable contraceptives over the other in
populations at high risk of HIV-1 infection.

Public health relevance
Observational clinical data suggest that the injectable contraceptive depo-medroxyprogesterone acetate (DMPA- IM) increases HIV-1 acquisition risk by 32-40% compared to another injectable contraceptive norethisterone enanthate (NET-EN). Our proposed study comparing immune biomarkers and peak serum progestin and endogenous hormone levels relevant to HIV-1 infection in archived samples from a clinical trial of women randomized to DMPA-IM and NET-EN, and comparable in vitro mechanism studies, will provide high quality evidence of plausible mechanisms as to whether these two injectable contraceptives are likely to have different effects on HIV-1 risk. Insights from this study will be relevant to clinical practice and public health, particularly in South Africa, regarding choice of injectable contraception in areas at high risk for HIV-1 acquisition, where DMPA-IM and NET-EN are used without discrimination, and may also impact on international guidelines to either reassure interchangeable use or suggest preferential use of one of these injectable contraceptives over the other in populations at high risk of HIV-1 infection.